T CELL TARGETING IN ALLERGIC PULMONARY INFLAMMATION

Asthma is characterized pathologically by the development of mucosal inflammation. The importance of bronchial inflammation in the pathogenesis of asthma remains poorly understood. Recent reports suggest that the T cell may play an important role in mediating this inflammation through the secretion of cytokines. A murine model of pulmonary inflammation will be used to study the role of the T cell in allergic pulmonary inflammation. The model is characterized by: l) the production of antigen specific IgE and IgG responses, 2) pulmonary inflammation consisting of eosinophils, neutrophils, monocytes and lymphocytes 3) the development of late-phase pulmonary responses and 4) the development of airway hyperresponsiveness. A unique series of bispecific monoclonal antibodies have been developed that are specifically designed to target activated T cells and T cell subsets. These reagents will be used to examine the role of the T cell in generating pulmonary inflammation, late-phase pulmonary reactions and airway hyperresponsiveness in the murine model. We will address the following specific questions: l. How does the development of antigen-specific T cell responses correlate with late-phase reactions and airway hyperresponsiveness following antigen challenge in this model? 2. Does T cell targeting at the time of antigen challenge, diminish pulmonary inflammation, late-phase reactions and airways hyperresponsiveness in appropriately immunized mice? 3. Can adoptive transfer of antigen-specific T cell clones into naive mice, followed by antigen challenge, induce pulmonary inflammation, late- phase pulmonary reactions and airway hyperresponsiveness or does it require the development of antigen-specific humoral responses? 4. Can the use of anti-T cell immunomodulating agents, administered in the presence of antigen, induce humoral unresponsiveness to antigen and T cell anergy in this model? 5. What are the respective roles of antigen-specific humoral and cellular responses in the development of pulmonary inflammation in this model?